Modelling structural and functional heterogeneity in heart failure reveals arrhythmic impact

PROJECT SUMMARY
The heart is a highly complex biological system. The overall goal of this project is to use multiscale computational
modeling of the heart from the molecular level to the organ level to identify the pro-arrhythmic effects of structural
and functional heterogeneity and elucidate molecular and ionic mechanisms of calcium (Ca2+) waves, delayed
afterdepolarizations (DADs), premature ventricular contractions (PVCs), and thus ventricular fibrillation (VF). A
key outcome will be to provide physiological bases for antiarrhythmic drug development, gene therapies, and
novel therapeutic strategies. The project builds on our recent discoveries 1) heterogeneous cell-to-cell coupling
promotes triggered arrhythmias at the tissue scale; 2) heterogeneous ryanodine receptor (RyR) distribution
promotes arrhythmogenic Ca2+ sparks and waves at the subcellular scale. The work proposed here is aimed
at bridging the knowledge gap between the tissue scale arrhythmia mechanisms and the subcellular scale
arrhythmia mechanisms utilizing multiscale computational modeling and the state-of-the-art experimental
approaches to measure detailed heterogeneity in the heart. Aim #1 is to establish link between RyR properties
and subcellular Ca2+ dynamics. To do this, we will extend this study and investigate heart failure (HF) cells, which
are supposed to be more heterogeneous. We will measure RyR distributions in normal and HF cells and build
the physiological and pathological models to test our hypothesis that heterogeneous RyR distribution promotes
Ca2+ waves, DADs, PVCs, and thus focal arrhythmias. Key questions that we will address in Aim #1 are: 1) how
RyR cluster size and spatial arrangements of RyRs at the cleft space affect Ca2+ sparks; 2) how RyR cluster
distribution in the cell promotes arrhythmogenic Ca2+ waves. RyR gating, and thus Ca2+ sparks and waves, are
also influenced by posttranslational modifications (PTMs). Aim #2 is to test the hypothesis that PTMs further
increase heterogeneous Ca2+ transients interacting with structural RyR heterogeneity. SERCA reuptake is
another key player in the Ca2+ cycling. Increasing SERCA pump activity increases SR Ca2+ load, which promotes
wave propagation. At the same time, increasing SERCA pump activity reduces cytosolic Ca2+ transients, which
suppresses wave propagation. In Aim #3, we test the hypothesis that increasing SERCA-pump function has a
biphasic effect on propensity of arrhythmogenic Ca2+ waves. When Ca2+ waves occur, they depolarize the cell
membrane and can lead to triggered activity in tissue. If cells are well-coupled, depolarization will be immediately
absorbed by surrounding cells. However, when cell-to-cell coupling is reduced, depolarization cannot be
absorbed by surrounding cells and PVCs occur more easily. However, at the same time, reduced cell-to-cell
coupling makes wave propagation more difficult. Therefore, we hypothesize that there is an optimal cell-to-cell
coupling for PVC formation (Aim #4). The proposed work will establish a new paradigm that a few irregular Ca2+
sparks can lead to the whole heart arrhythmias when cardiac heterogeneity is increased in HF and other
pathological conditions.

Public health relevance
PROJECT NARRATIVE In this project, we will study mechanisms of sudden cardiac death, which is the major cause of death in the United States, using computational and experimental approaches. The heart is a highly heterogeneous organ, both at a regional and subcellular level. This project is aimed at bridging the knowledge gap between the tissue scale arrhythmia mechanisms and the subcellular scale arrhythmia mechanisms utilizing multiscale computational modeling and the state-of-the-art experimental technique.